The role of antibodies in infant TB prevention

ABSTRACT
Summary of Proposal
This proposal describes a 5-year training and research plan that will allow Lisa Cranmer, MD, MPH to build on
her background in global pediatric TB/HIV and molecular epidemiology and gain critical skills in immunology and
advanced biostatistics. In order to become an independent investigator focused on understanding immune
mechanisms to prevent TB in children with a unique niche in maternal-infant immunology, Dr. Cranmer will
develop additional skills in: 1) humoral and innate immunology methods, 2) advanced longitudinal data analysis,
and 3) vaccinology. Dr. Cranmer will leverage her substantive field research experience in Kenya using ongoing
cohorts of mother-infant pairs and will receive close mentorship from researchers with over 30 cumulative years
of experience performing molecular epidemiology studies and vaccine trials in high TB/HIV burden settings.
Using these resources, Dr. Cranmer will develop the expertise to lead future TB vaccine trials in mothers and
infants.
Research Plan
In TB-endemic settings, HIV-exposed uninfected infants have >20-fold higher risk of Mycobacterium tuberculosis
(Mtb) infection compared to HIV-unexposed uninfected infants. Up to 40% of Mtb-infected infants develop TB
disease with high morbidity and mortality. Current strategies to prevent Mtb infection in HEU infants, including
BCG vaccination and primary isoniazid preventive therapy, have not been successful. In order to design new
prevention strategies, Dr. Cranmer will evaluate the role of antibodies in protection of HEU infants from Mtb
infection, and examine if maternal HIV exposure leads to changes in infant Mtb antibody-mediated innate
immunity. Dr. Cranmer will evaluate if Mtb antibody levels or antibody-dependent cellular phagocytosis
(ADCP)/antibody-dependent cellular cytotoxicity (ADCC) function in mother-infant pairs will confer protection
against infant Mtb infection (Aim 1). She will then compare Mtb antibody-mediated immunity (e.g. antibody
function and innate immune cytokine expression) to understand potential mechanisms of increased susceptibility
to Mtb infection among Kenyan HEU infants (Aim 2). The proposed aims are designed to generate novel data
that enhance our understanding of TB pathogenesis and inform development of innovative public health
strategies to prevent infant Mtb infection, including new maternal and infant vaccines.

Public health relevance
NARRATIVE Lisa Cranmer, MD, MPH, is an Assistant Professor in the Division of Pediatric Infectious Diseases at Emory University School of Medicine. For the proposed K23 award, Dr. Cranmer will pursue training in immunology, vaccinology, and advanced biostatistical methods to investigate whether Mtb antibodies protect HIV-exposed infants from Mtb infection (Aim 1) and identify differences in Mtb humoral and innate immunity between HIV- exposed and HIV-unexposed infants (Aim 2). The research findings will define the role of Mtb antibodies in infant TB immunity and inform development of vaccination strategies that will form the basis of Dr. Cranmer’s independent research career in infant TB prevention.